Enhanced Training and Mentorship of Hematologic Oncologists

Project Summary
Hematologic malignancies are a major health problem. There are approximately 1.2 million people in the United
States living with leukemia, lymphoma, or myeloma, and these malignancies accounted for 10% of all new cancer
diagnoses in 2016.1 Fortunately, the field of has experienced robust and promising advances in recent years.
However, many patients with hematological malignancies continue to have unacceptable outcomes,8-10 and
much work remains to improve their survival. Furthermore, patient-reported outcomes and cost-effectiveness
are becoming key issues that are relevant to patients.
In an effort to further advance the field of hematological malignancy and to improve patient outcomes, the
American Society of Hematology (ASH) created the Clinical Research Training Institute (CRTI) 14 years ago to
train junior researchers in the conduct of patient-oriented research and provide them the networks and
mentorship to succeed in these careers.
CRTI is a year-long program that annually exposes 20 fellows (applicants who at the time of their application
and for the duration of the CRTI program are in hematology-related fellowship training) and junior faculty
(applicants have completed their fellowship training within the past three years) to foundation, methodologies,
and application of patient-oriented clinical research. Each fellow receives (1) extensive education in clinical
research methods; (2) one-on-one exposure to leaders in the field of cancer research; (3) the opportunity for
junior investigators to form peer networks; and (4) formal mentorship from successful clinical researchers. The
Institute consists of a week-long Summer Workshop that includes interactive didactic presentations, small group
discussions, training in the responsible conduct of research, and numerous hours of one-on-one and ad hoc
group discussions. The Summer Workshop (in August) is followed by the December Class and the Final Class
(in May) during which the entire class convenes to discuss their progress and obstacles. Each trainee identifies
a CRTI mentor with whom he or she works during the entire program year to ensure career and research
progress. Under this grant, we intend to expand the training curriculum to incorporate innovative teaching
strategies, introduce new sessions consistent with current priorities such as patient engagement and precision
medicine, enhance dissemination of the program through on-line resources, and increase connections via web-
based approaches.

Public health relevance
Project Narrative Under this grant, “Training and Mentorship of Hematologic Oncologists,” the American Society of Hematology (ASH) will train and mentor emerging clinician scientists focused on patient oriented research aimed at hematological malignancies including leukemia, lymphomas, and myeloma. Researchers trained through the ASH Clinical Research Training Institute will conduct research that improves the diagnosis and treatment of these diseases, leading to improved survival and quality of life. The program and its graduates will ensure that the advances being made in laboratories are successfully translated to clinical trials and clinical care to improve the health of patients suffering from malignant blood diseases.